UCB L059 IN CHILDREN W/ PARTIAL ONSET SEIZURES

The purpose is to determine the effectiveness and tolerability of ucb L059 given in a twice daily regimen to existing AED treatment and to also determine the pharmacokinetic parameters (the measuring of the drug in the blood and urine) of both ucb L059 and its breakdown product ucb L057 in the age group of 6 to 12 years.